Modulation of Lifespan and Healthspan by Meiosis Genes

ABSTRACT: Modulation of Lifespan and Healthspan by Meiosis Genes
The impact of advanced maternal age on fertility decline is well established, but how germline fitness influ-
ences organismal health and aging remains unclear. It is known that reproductive defects augur detrimental
long-term consequences in both sexes. For instance, early age-at-natural-menopause (ANM) has been linked
to greater risk of mortality. Women with late ANM exhibit younger ‘epigenetic aging’ profiles and brothers of
women with prolonged reproductive longevity show extended lifespan. Menopause itself triggers susceptibility
to a host of comorbidities unrelated to reproduction such as cardiovascular disease and dementia, as does tes-
tosterone decline in men. Thus, a compelling body of clinical and epidemiological evidence indicates that
germline status influences overall organismal health and aging. However, human studies do not address cau-
sality nor reveal the mechanisms by which the immortal germline may influence aging of the mortal somatic
tissues.
We have utilized the unique strengths of Caenorhabditis elegans to assess how perturbing meiosis, a pro-
cess that occurs exclusively in germ cells, impacts the length of life and rate of aging of the animal. This pro-
posal is based on our discovery that disruption of meiosis accelerates somatic aging. We found that mutations
in C. elegans genes operating at different steps of meiosis shortened lifespan, impaired healthspan and desta-
bilized protein homeostasis. Importantly, meiotic mutants exhibited prematurely aged transcriptional profiles
reminiscent of old C. elegans and aging human tissues, suggesting that germline dysfunction triggers a con-
served molecular-aging signature. Thus, we hypothesize that genes that govern meiotic fidelity in germ cells
influence organismal lifespan and healthspan.
Our study has revealed a hitherto unknown link between the nuclear events of meiosis in germ cells and
the aging of both the gonadal tissue and the organism. This exploratory study aims to find the missing links in
this pathway: what are the signals between the germ line and soma that lead to organismal aging (Aim 1),
does the meiotic nuclear dysfunction lead to aging of the gonad as well and how is this connected to somatic
aging (Aim 2). Notably, many of the genes we studied have human homologs with roles in mammalian meiosis
and have been implicated in reproductive senescence. The transcriptional similarities we identified between
meiosis mutants and aging human tissues suggest avenues to unravel potential evolutionarily conserved
mechanisms underpinning the meiotic control of health and longevity. This study will establish the foundation
for future mechanistic- and conservational- studies.

Public health relevance
NARRATIVE It is increasingly becoming apparent that reproductive fitness has a major impact on the overall health and aging of the individual but little is known about the mechanisms underlying. This project utilizes the model nematode, C. elegans, to identify genes that determine how meiosis in germ cells influences overall aging. The research has relevance for human health and high public-health significance because human counterparts of genes being studied here have been implicated in human reproductive aging, so the findings from this work may help design therapies for age-related diseases, especially those pertaining to reproductive health.